Joint Cell Isolation Core of the MARC

JOINT CELL ISOLATION CORE ABSTRACT
The Joint Cell Isolation (JCI) Core of the Microenvironment in Arthritis Resource Center (MARC) will facilitate
research in the San Diego community focused on the biology of the joint at the tissue and single cell level. The
JCI Core will serve as a local resource for technologies such as laser capture microdissection (LCM) and flow
sorting from joint tissues. No other shared resource in the San Diego area offers this type of expertise or
service. The JCI Core will be led and managed by faculty and staff with extensive experience in the application
of these technologies to research on rheumatologic diseases. The Core will provide a series of operator-
assisted services for LCM, tissue disaggregation, and flow sorting from human and mouse joint tissues. The
Core will also help with experimental design, collaborate with investigators to tailor protocols to the needs of
the individual researcher, and engage in its own internal research to develop new cutting-edge methodologies
for investigation into the joint microenvironment. The Aims of this Core are 1) to assist investigators in the
design of experiments to isolate tissue fragments and/or single cells from human or mouse joints, 2) to assist
investigators in the execution of experiments involving isolation of cells in situ from joint tissue histologic
sections via LCM, and 3) to assist investigators in the execution of experiments involving disaggregation of
joint tissue and sorting of specific cellular populations. The Core will also facilitate interactions with other
shared resources to help investigators with needs related to the workflow for these experiments, such as
procurement of synovium or cartilage samples, histological preparation of tissues, and obtaining samples that
can be analyzed by transcriptomics or other technologies like chromatin accessibility. By providing services
and expertise, the MARC JCI Core will enable researchers in the local community to use techniques previously
unavailable to them and will add a new dimension to their research programs.